Computational Module

Project Summary
Vision research has accelerated toward a need to not only understand how visual stimuli are received and
processed in the brain, but towards the need to understand how the brain interprets, predicts, and ‘reasons’
about what it is seeing. Machine learning/computer vision (ML/CV) approaches are now essential tools to test
theories of deep vision/higher order vision, and investigators at Harvard have pioneered the development of
these algorithms to make fundamental discoveries regarding object and face recognition. To further develop this
research program, the Vision Core is launching a Computational Module that will support the development of
new methods in this area, and to provide expertise to vision labs that seek to apply ML/CV methods to their
research. The Module will be staffed by a ML/CV Specialist who will generate new models, create pipelines to
train models, and also curate models for the community. Vision researchers will specifically benefit from this
resource through access to a dedicated node on the HMS high-performance computing cluster, O2, which will
be managed by the ML/CV specialist. Lastly, the Computational Module will provide training and educational
workshops to the vision community to support the next generation of trainees interested in this highly impactful
area of research. The Module will be supervised by Dr. Gabriel Kreiman, a leading expert in the use and
development of ML/CV models in vision research, and a longstanding user of the Vision Core. By generating a
set of accessible expertise and resources for the vision community, the new Computational Module will catalyze
progress in this critical area of vision research.